High-Resolution Mapping of Bacterial Transcriptional Responses in Human-Associated Microbiota

Project Summary
Functional profiling of microbial communities is critical to understanding their overall effects on host health. Most often,
metagenomic shotgun sequencing of microbiome samples is used to assess total functional capacity. Yet, transcriptional
responses may vary dramatically between organisms depending on the context, with potentially large effects. Many
metabolic functions are only expressed after the organism acutely senses the presence of particular substrates in their
environment. Pathogens may only express virulence factors after obtaining a critical quorum of pathogens. Overall, stress
responses are critical for survival under changing abiotic and biotic conditions. Being able to comprehensively map out
these pathways, which determine the resilience, plasticity, and patho-functions of the microbiome, requires sensitive,
robust transcriptional –omics tools.
Performing traditional RNAseq analyses on bacterial communities has been the predominant method to gain
transcriptional information, but it is hampered by the need for technical workarounds and it provides incomplete
information about the transcriptional landscape. Ribosomal RNA needs to be depleted prior to sequencing, it has a poor
signal-to-noise ratio arising from varying RNA decay rates, and it is insensitive to the transcription of non-coding RNA
that has secondary structure or post-transcriptional modifications. Alternatively, the position of RNA polymerase (RNAP)
can be assessed, which provides a real-time readout of transcription. Although so-called nascent transcript sequencing has
been performed in E. coli, revealing transcriptional pause sites and other phenomenon elusive when using RNAseq alone,
these protocols rely on immunoprecipitation of RNAP and are therefore unsuitable for complex microbial communities
where RNAP may be quite diverse and require species-specific antibodies. As a solution, Precision Run-On and
SEQuencing (PRO-seq), a method originally created for examining transcription in eukaryotes, may provide an unbiased
method to examine transcriptional dynamics on cultured bacteria or in complex microbial communities, such as the
human microbiome.
Our goal is to test the feasibility of PRO-seq when applied to prokaryotes and to evaluate its ability to capture
transcriptional dynamics associated with canonical stress response pathways (heat-shock, oxygen exposure and DNA
damage), using a set of quantitative metrics. We aim to validate, and if necessary, modify the protocol so it can be used
robustly across species. We plan to develop a computational approach to test the full breadth of transcriptional phenomena
that can be observed using this method, such as transcriptional pausing, bidirectional transcription, differences in RNAP
function apparent across species, and RNA decay rates, among other aspects. If successful, we expect that PRO-seq will
be adopted to study the responses of human-associated microbiota to host diet, inflammatory signals, xenobiotics and to
human transcriptional circuitry, more directly.

Public health relevance
Project Narrative Bacterial communities react to environmental stressors, the presence of oxygen in the gut, for example, by changing their transcriptional landscapes, and these responses underlie microbiome-related disorders such as inflammatory bowel disease (IBD), and colorectal cancer (CRC). Although RNAseq has been used to profile community function to obtain dynamic functional information not captured by metagenomic DNA sequencing alone, RNAseq is unable to capture real-time dynamics due to the varying stability of RNA, requires additional steps to remove ribosomal RNA, and isoften insensitive to short non-coding or modified RNA. We propose the development of Precision Run-On and SEQuencing (PRO-seq) as a promising method to capture transcriptional dynamics in cultured prokaryotes and in complex microbial communities, such as the human microbiome.